Uncovering Neural Substrates of Diminished Temporal Binding Capacity in Aging

Temporal binding capacity, which enables the relational association of discontiguous stimuli and events,
diminishes with normal aging and aging-associated neuropsychiatric disorders. Decline in this key mental
function is a major limiting factor underlying aging-associated cognitive and affective impairment. The global
economic burden of such aging-associated impairment is estimated at over $1 trillion and is growing at an
alarming pace. An improved understanding of changes in neural functions with aging that contribute to degraded
temporal binding capacity could greatly facilitate the long-term objective of alleviating cognitive and affective
impairments in normative aging and aging-associated neuropsychiatric disorders. Yet, the changes in circuit and
network functioning contributing to diminished temporal binding capacity with aging remain unknown. The
Principal Investigator's recent NIH-funded work using trace fear learning paradigms has identified critical
neural activity dynamics in the CA1 output region of the hippocampus (HPC) supporting the encoding and
representation of emotionally salient associations during temporal binding in young adult subjects. This
framework will now be extended to uncovering altered processes in aged subjects. The current project utilizes a
novel, conceptually innovative model for temporal binding based upon previously uncharacterized functioning
of a known CA1 radial sublayer-biased microcircuit motif and proposes that alterations in subpopulation activity
and network dynamics may underlie age-related impairment of temporal binding capacity. Based on prior data
the model predicts that, in early adulthood, deep CA1 pyramidal cells (CA1PCs) output stimulus representations
across discontiguous gaps for temporal binding, while learning-related increases in sharp-wave ripple (SWR)
event incidence facilitate consolidation of relational associations outside of the behavioral episode. Aging-related
alterations in sublayer-biased signaling during temporal binding and/or SWR dynamics during consolidation of
relational associations may thus underlie diminished temporal binding capacity in aging. In future work, any
alterations uncovered here will then be used to inform novel strategies for improving temporal binding capacity
with aging and alleviating impaired relational organization and affective associations in memory. To uncover
aging-related alterations in neural dynamics supporting temporal binding capacity, the project combines state-
of-the-art techniques including 2-photon imaging of subcircuit activity, electrophysiology, and optogenetic
triggering of network activity events in awake, behaving mice. In Aim 1, aging-related changes in the CA1 radial
sublayer outputs mediating temporal binding for trace fear memory acquisition will be identified. In Aim 2,
aging-related alterations in SWR activity for consolidation of relational fear associations will be uncovered. The
proposed studies are aligned with NIH objectives and will advance the understanding of the neural processes
underlying the decline in temporal binding capacity with aging, which is essential to improving therapeutics for
cognitive and affective impairments across the normal lifespan as well as in aging-associated disorders.

Public health relevance
The ability to form declarative memories declines with normal aging as well as aging-associated cognitive and emotional disorders. Diminished temporal binding capacity, which normally allows for the association of non- overlapping stimuli and events in an experience, is a core process underlying such impairment with aging. This project will identify aging-associated alterations in brain activity functions supporting temporal binding capacity with the long-term aim of identifying potential targets to slow or alleviate cognitive and emotional impairments in aging and aging-associated neuropsychiatric disorders.